Basic Science Core - Biosafety & Biocontainment Core (BBC)

Texas Biomed IN-TRAC Biosafety & Biocontainment Core (BBC) – ABSTRACT
The goal of this core is to establish a personalized Biosafety & Biocontainment training curriculum for the next
generation of tuberculosis (TB) researchers in order to prepare them to work and excel within the biocontainment
environment performing studies to advance the field. For a new investigator pursuing TB research as well as for
well-established investigators who want to enter the TB research field, it is critical for them to understand
biosafety and the biocontainment environment, including knowledge of the strengths and limitations of working
in biocontainment, in order for them to achieve their career goals. The ability to properly conduct risk assessment
including a thorough understanding of equipment and procedures in biocontainment, will further ensure
innovations in TB research, especially in resource limited areas. Our Aims are to: Aim 1. Establish and manage
a personalized Biosafety & Biocontainment curriculum. In this Aim a phased approach (assessment and
didactic phases) will be implemented to provide comprehensive and customized training. Aim 2. Execute a
Biosafety & Biocontainment training program for IN-TRAC participants. In this aim, a personalized
Biocontainment training program established for each IN-TRAC participant will be executed. Participants will
learn how to function safely and effectively in a high-containment BSL3 facility. We will divide this into three
segments: Biocontainment facility operations, General Procedures and Emergency Response Drills. Aim 3.
Apply risk assessment and mitigation strategies to emerging technology and multi-hazard scenarios.
New technology often introduces unforeseeable biosafety risks. Equipped with general biocontainment and M.tb
procedure-specific knowledge, participants will be able to properly evaluate and implement procedures when
encountering emerging technology and develop procedures to safety achieve their research goals.
Upon completion of this core curriculum, new TB researchers will be prepared/proficient in working in a
biocontainment environment, including general and specialized techniques required for success in the TB field.
Importantly, IN-TRAC participants will prepare a written and oral summary about the strengths and weaknesses
of experience for the IN-TRAC program.